Implementation and Evaluation of a Screening Tool for Sexual Dysfunction for Pediatric Cancer Survivors

PROJECT SUMMARY/ABSTRACT
Background: Sexual dysfunction (SD) is estimated to occur in up to 50% of childhood cancer survivors (CCS)
and has important implications for quality of life and mental health. Effective management of SD in AYA-CCS is
substantially limited due to lack of screening and detection of SD in cancer survivorship settings. Adolescent and
young adult-aged CCS (AYA-CCS) may be particularly vulnerable to SD and its under-recognition due to
developmental challenges. This study addresses this critical barrier and serves as the first step in progressing
toward the long-term goal of improving health-related quality of life in AYA CCS through improved screening,
recognition and treatment of SD among CCS. Candidate: The proposed award will enable the candidate, Dr.
Sopfe, to develop the skills necessary to progress toward her career as an independent researcher leading high
quality pragmatic trials. Training: Specifically, Dr. Sopfe will gain experience in Dissemination & Implementation
(D&I) science, pragmatic clinical trials, and mixed methods, which will propel her toward a research career aimed
at developing and disseminating interventions to improve quality of life for CCS. In addition to experiential training
through the research plan, Dr. Sopfe will benefit from a multidisciplinary mentorship team: Primary Mentor, Dr.
Peterson (hybrid trials, qualitative research, patient-reported outcomes); Co-Mentor, Dr. Chow (pediatric cancer
survivorship, clinical trials); and Methods Mentor, Dr. Studts (D&I, mixed methods). Dr. Sopfe’s training plan
includes formal didactic coursework, workshops, and career development programs. Research Plan: This
proposal’s overall objective is to use patient and provider stakeholder input to refine and test an approach to SD
screening for AYA CCS in a clinic setting. Informed by D&I frameworks, this research proposal will used mixed
methods and iterative testing and modification to refine an SD screening approach (Aim 1). This approach will
be then tested in a pilot type 1 hybrid effectiveness-implementation study (Aims 2 and 3), employing mixed
methods to assess patient and provider outcomes. Environment: The environment for this project is exceptional
with a strong academic Section of Pediatric Hematology/Oncology/BMT at the University of Colorado, the
resources of the University of Colorado Adult and Child Consortium for Health Outcomes Research and Delivery
Science (ACCORDS) (D&I Science Program, Qualitative & Mixed Methods Research Core). The clinical trial will
occur through the 1) Children’s Hospital Colorado (CHCO) HOPE Survivorship Program; CHCO Neuro-Oncology
group; and 3) Seattle Children’s Hospital Cancer Survivorship Program. This multiclinic design will ensure
successful recruitment as well as increase generalizability of findings. Impact: The proposed study will serve as
a necessary first step in improving screening, detection, and treatment of SD in AYA-CCS; future work will include
establishing broader effectiveness our screening approach through a multicenter randomized trial, as well as
development, testing, and dissemination of multidisciplinary interventions for SD in this population.

Public health relevance
PROJECT NARRATIVE Long term survivors of childhood cancer, of which there are over 400,000 in the United States, have increased chronic and mental health conditions and reduced health-related quality of life and socioeconomic attainment than their peers. One such long term effect, sexual dysfunction, is identified by adolescent and young adult- aged childhood cancer survivors (AYA-CCS) as a bothersome yet unmet need affecting their mental health and quality of life. Completion of this study will lead to improved screening and diagnosis of sexual dysfunction among AYA-CCS, which is the first step in improving quality of care for this underrecognized and undertreated condition.